Acquisition of a MicroCal PEAQ-ITC Automated

PROJECT SUMMARY
This application is for a shared isothermal titration microcalorimeter (ITC) facility. ITC technique enables the
accurate determination of ligand receptor dissociation constants and complete thermodynamic parameters,
which will strengthen the research projects of a group of very productive NIH-supported faculty members in
medicinal chemistry, pharmacology & toxicology, chemistry & biochemistry, molecular biology, and biophysics
at the University of Arizona (UA). These investigators are funded by NIH to study the design and synthesis of
small molecules for novel therapeutic targets, to develop small-molecule probes to perturb biological processes
associated with various diseases, or to investigate intermolecular interactions driving biological processes. Their
research addresses a wide variety of unmet medical needs, including microbial infections, neurological disorders,
diabetes, and cancer. Currently, there is no ITC at the University of Arizona with low sample volume and
automated sample handling capabilities. The requested instrument will have a significant impact on a large group
of NIH-supported major and new users, particularly for hit validation from high throughput screening and
medicinal chemistry campaigns. Further, we are confident that the new ITC will stimulate new collaborations
among investigators at UA. The Arizona Center for Drug Discovery (ACDD) will house the instrument and provide
user training for the ITC, while College of Pharmacy and the Office of Research, Innovation and Impact (RII) will
support for the service contract. Scheduling of the instrument will be through web-based iLab Organizer, and
any conflicts will be resolved through an advisory committee.

Public health relevance
PROJECT NARRATIVE The MicroCal PEAQ-ITC Automated isothermal titration calorimeter will allow us to investigate research questions of considerable human health importance in a more efficient way. Specifically, this equipment is required to advance funded research in both basic and translational sciences. It directly and more efficiently allows measurement of binding affinity and thermodynamic parameters of intermolecular interactions driving biological process.